Clec12A regulation of the intestinal immune response and microbiota composition

ABSTRACT
Inflammatory bowel disease (IBD) affects over 3 million people in the United States alone. IBD is caused by
excessive gastrointestinal tract inflammation and depends on the microbiota. The intestinal immune response to
the microbiota must be regulated to prevent inflammatory diseases such as IBD. The intestinal immune system
can interact with the microbiota via pattern recognition receptors (PRRs), including the inhibitory C-type lectin
receptor, Clec12a. Previously, we have determined that Clec12a can bind specific commensals within the
intestine. Clec12a has inhibitory capacities, making it a unique PRR for commensal recognition, as it could act
as a brake on immune proinflammatory signaling in this microbe and microbial ligand-rich environment. Clec12a
is downregulated in individuals predisposed to IBD, suggesting a role for Clec12a in disease development.
Interestingly, Clec12a-/- mice have more proinflammatory macrophages and less reparative macrophages,
emphasizing that in the absence of Clec12a, there is a dysregulation in the immune response. Further, Clec12a-
/- mice exhibit worsened colitis that is microbiota dependent, exemplified by the microbiota being sufficient to
drive worsened colitis in WT mice. A major feature of the Clec12a-/- microbiota is a significant expansion of the
gram-positive bacteria Faecalibaculum rodentium. These data suggest that Clec12a might dictate microbiota
composition by limiting the expansion of harmful bacteria. In fact, Clec12a binds F. rodentium in a species-
specific manner. Due to Clec12a having the highest expression on macrophages and monocytes in the gut, we
tested whether Clec12a functioned in phagocytosis and observed that Clec12a-/- macrophages phagocytosed F.
rodentium at lower levels, and this was also species-specific. Therefore, this proposal aims to identify how
Clec12a regulates intestinal inflammation (Aim1) and how Clec12a dictates microbiota composition (Aim2). I will
use a novel Clec12a-floxed mouse, allowing for the deletion of Clec12a in a cell-specific manor, while analyzing
the effects on inflammation and microbiota composition. This proposal will determine the mechanism by which
Clec12a restrains intestinal inflammation and sculpts the microbiota. Our working hypothesis is that Clec12a on
transepithelial sampling myeloid cells can control the outgrowth of potentially harmful members of the microbiota
through phagocytosis while also constraining harmful inflammatory events.
We will test this hypothesis by completing these two aims:
AIM 1: Determine how Clec12a regulates intestinal inflammation.
AIM 2: Resolve how Clec12a sculpts the intestinal microbiota.
This proposal will lay the groundwork for targeting Clec12a, and its inhibitory capacity, to treat IBD. Clec12a is a
unique mechanism the immune system employs to sculpt the microbiota without eliciting prototypical
inflammation. This mechanism could unveil treatments for other diseases that are influenced by the microbiota.

Public health relevance
Project Narrative The ultimate goal of the proposed research is relevant to public health because identifying targets to dampen inflammation during IBD will allow for improved treatments. Due to the rising prevalence of IBD, new treatments are urgent, and Clec12a provides a novel target for IBD due to its inhibitory function. Our preliminary data suggests Clec12a function is crucial for intestinal homeostasis and mice lacking Clec12a expression exhibit excess inflammation and worsened colitis compared to WT mice; therefore, this grant aims to determine how Clec12a functions in the context of the intestine, particularly how Clec12a regulates the intestinal immune response to the microbiota.